Mapping and Targeting Focal Sources Before and After Surgical Ablation of Atrial Fibrillation

Project Summary/Abstract
Atrial fibrillation (AF) is the most common tachyarrhythmia, with the number of Americans diagnosed
estimated at more than six million. It is associated with an increased risk of stroke, heart failure, and all-cause
mortality. In patients with paroxysmal AF, which most often is initiated by triggers from the pulmonary veins
(PVs), pulmonary vein isolation (PVI) has been relatively effective in treating AF. However, in patients with
persistent and long-standing persistent (LSP) AF, ablation treatment of AF, which includes PVI, has been only
modestly effective because of the lack of patient-specific “mechanistic” targets to ablate. As a result, the
ablation procedure is largely an empiric “one size fits all” approach. To emphasize that fact, recent clinical trials
in patients with persistent and LSP AF involving endocardial catheter ablation or surgical ablation showed that
there was no significant difference in the rate of freedom from AF between patients who underwent PVI alone
and those who underwent PVI plus additional empiric ablation lesion sets. Furthermore, ablation lesions
beyond the PVI significantly increased the need for implantation of a permanent pacemaker. All this supports
the need for 1) identifying the mechanism(s) that maintain AF by activation pattern; 2) understanding the
effects of each ablation lesion set on atrial activation patterns responsible for maintaining AF so that we can
determine what changes in activation patterns created by the ablation lesion are critical for terminating AF and
preventing its recurrence. Thereby, ablation therapy of persistent and LSP AF could change from a largely
empiric approach to a patient-specific targeted approach. Our recent studies using simultaneous, biatrial, high
density (510 - 512 electrodes), epicardial contact mapping in patients with persistent and LSP AF undergoing
open heart surgery found that wave fronts emanating from focal sources and breakthrough sites maintained
AF. Also, our preliminary studies in patients with persistent and LSP AF showed that AF was still present
immediately after surgical ablation, and was associated with continued activation patterns described above.
The central hypothesis of this proposal is that persistent AF after surgical ablation is due to the continuation of
baseline focal sources maintaining AF, and that interrupting their activation will terminate AF. The hypothesis
to be tested has three specific aims: Aim 1 is to identify focal sources in patients with persistent and LSP AF.
Aim 2 is to test the hypothesis that a continuation of wave fronts emanating from focal sources after surgical
ablation (PVI ± additional linear ablation lines) maintains AF. We will investigate the effects of each ablation
lesion set on the activation behavior of baseline focal sources and breakthrough sites. Aim 3 is to test the
hypothesis that targeted ablation of focal sources will reliably terminate AF. We will develop an efficient
ablation strategy for targeting focal sources to improve patient safety by decreasing the amount of tissue
ablated permanently. Insights provided by data from our proposed study should contribute importantly to the
ablative approach, the improvement of both care and clinical outcomes in patients with persistent and LSP AF.

Public health relevance
Project Narrative Atrial fibrillation (AF) is the most common disorder of the heart rhythm in the Western World, and is an enormous and growing clinical problem. The studies in this research proposal will contribute importantly to improved ablation therapy and outcomes in patients with persistent and long-standing persistent AF, and thereby, lead to greatly improved treatment of this important cardiac rhythm disorder.